RNA helicases in bacterial pathogenesis

PROJECT SUMMARY
The ability of bacteria to rapidly sense and respond to changes in the environment is fundamental
to colonization and survival. Post-transcriptional regulation is emerging as an important strategy that
promotes efficient and precise control of bacterial virulence, and thus plays a central role in
pathogenesis. Enterohemorrhagic Escherichia coli O157:H7 (EHEC) is a bacterial pathogen that
colonizes the human colon and causes severe hemorrhagic colitis and hemolytic uremic syndrome
(HUS), which can be fatal. EHEC encodes several important virulence factors, including the potent
Shiga toxin that causes HUS and a type three secretion system (T3SS) and effectors necessary for
attaching and effacing (AE) lesion formation on enterocytes. EHEC has a very low infectious dose,
suggesting that EHEC has evolved mechanisms to spatiotemporally control virulence gene
expression to occur within appropriate host niches. RNA helicases are ubiquitous in all kingdoms of
life, as well as within viral genomes, and are involved in virtually all aspects of RNA metabolism,
including RNA degradation or protection and translation. Our studies underlie the importance of RNA
helicases to EHEC niche adaptation and coordination of virulence gene expression. The proposed
work will investigate the importance of RNA helicases to niche recognition and host-pathogen
interactions using a physiologically relevant infection model. We will also utilize unbiased approaches
to comprehensively map the regulon of an EHEC helicase and identify targets of regulation.

Public health relevance
PROJECT NARRATIVE To colonize a host and cause disease, bacterial pathogens must rapidly respond to changes in the host environment in order to scavenge nutrients and appropriately regulate gene expression. This application is designed to examine how the bacterial pathogen E. coli O157:H7 relies on RNA helicases to modulate gene expression and thereby enhance growth and pathogenesis.